Behavioral Intervention to Mitigate Nicotine Addiction in Digital Environments

Smoking remains highly prevalent among socioeconomically disadvantaged populations, where nicotine addiction is particularly stubborn despite conventional treatment approaches. This project proposes a behavioral intervention to mitigate nicotine addiction by testing evidence-based strategies within a rigorously recruited sample of smokers. The research focuses on users of flavored combusted tobacco products and aims to evaluate the impact of message characteristics on smoking cessation-related outcomes. A multi-phase approach will be used, beginning with qualitative methods and co-creation workshops to develop message content tailored for digital platforms. These messages will then be evaluated through an eye-tracking study and a discrete choice experiment to quantify how users respond to specific message attributes. Finally, a randomized clinical trial (RCT) will test the effects of these messages on behavioral outcomes among a nationally representative sample of individual tobacco users. The proposed work is an individual-level behavioral intervention designed to improve tobacco education efficacy among participants. By examining how targeted intervention components influence the intention to quit smoking and related cessation behaviors, this project will generate insights that inform clinical practice guidelines for smoking cessation among people who smoke.

Public health relevance
PROJECT NARRATIVE To address persistent disparities in combusted tobacco product use, novel communication approaches through digital channels are needed. Using an innovative combination of qualitative, eye tracking, and quantitative (discrete choice experiment, randomized clinical trial) studies, we will develop and test messages to reach low- SES smokers. Results will will help eliminate tobacco-related disparities and increase the effectiveness of tobacco educational messages among the population for whom anti-tobacco messages have not been optimally effective.